Unraveling effects of gut and blood microbial signatures on immune phenotypes and organ dysfunction in sepsis

Project Abstract/Summary
Sepsis is among the leading causes of death in the intensive care unit, and therapies that combat the
dysregulated host response underlying its high morbidity and mortality remain elusive and urgently needed.
Animal studies indicate that the gut microbiota plays a critical role in host immune responses, and modulation
of microbiota structure or function may be an effective strategy in the treatment of sepsis. However,
development of similar therapies for clinical practice first requires a better understanding of the relationships
between the gut microbiota and immune status in septic patients. Due to the increased intestinal permeability
associated with sepsis, delineating these host-microbe interactions also requires the consideration of gut-
derived microbial products in the blood, and their potentially distinct influences on immune responses.
Emerging evidence using modern sequencing techniques demonstrates that microbial products (including
lipopolysaccharide) from gut microbes are not universally pro-inflammatory, but rather, transmit species-
specific signals to immune cell toll-like receptors (TLRs) that differentially influence nuclear factor-κB activation
and cytokine responses. Changes in gut microbial community structure and collateral effects on the
composition of blood microbial signatures thus may contribute to the degree of systemic immune activation in
sepsis. However, interactions between gut and blood microbial signatures and immune responses have never
been simultaneously explored in septic patients. This proposal aims to unravel these relationships, using a
meta-systems approach to integrate gut microbial community profiling, metabolomics, measures of intestinal
permeability, and blood microbial signatures with immune phenotypes and clinical endpoints in a prospective
longitudinal cohort study of ICU patients with sepsis. These investigations will reveal how changes in the
microbiota in sepsis – compared to critical illness alone – influence blood microbial signatures and burden, and
if specific gut and blood microbial signatures relate to, or are predictive of, immune activation/exhaustion and
end-organ dysfunction. Additionally, biochemical, sequencing, and peripheral immune cell assays will be used
to investigate if distinct blood microbial signatures identified in septic patients differentially modulate innate
immune cell TLR activation and cytokine production. The findings from this study will enhance our
understanding of microbiota-immune interactions and have the potential to reveal novel therapeutic
approaches that are urgently needed for this lethal disease.

Public health relevance
Project Narrative Sepsis is the leading cause of death in the intensive care units (ICU) and represents a dysregulated host response to infection. The composition of the gut microbiota during sepsis and early in ICU course may influence acute immune responses and ability to defend against subsequent infection. This investigation will reveal how changes in the gut microbiota and their associated products that enter the blood influence immune activation and exhaustion and organ dysfunction in acute and later stages of sepsis – findings that can inform development of urgently needed new therapies.